Interspecies reservoirs of antibiotic resistance for Neisseria gonorrhoeae

PROJECT SUMMARY
Antibiotic resistance in Neisseria gonorrhoeae is an urgent threat to public health, with the emergence
of strains resistant to current clinically-approved antibiotics, and infection rates simultaneously rising (up
92% since 2009). Substantial effort has been spent on identifying resistance mechanisms to antibiotic
therapies currently circulating within the gonococcal population. However, these surveys often overlook
a known source of resistance for gonococci – the commensal Neisseria. Neisseria promiscuously share
DNA with one another, which has been demonstrated to facilitate rapid adaptation and evolutionary
change. For example, the majority of reduced susceptibility to both azithromycin and ceftriaxone in N.
gonorrhoeae populations has been acquired though horizontal transfer and subsequent spread of
commensal alleles. As resistance has been shown to be directly selected for in commensals after
antibiotic usage in patients, these species will always be a persistent threat for resistance donation to
N. gonorrhoeae. Thus, the overall goal of this project is to profile the Neisseria resistome, or the total
collection of antibiotic resistance mechanisms available to members within the genus. The knowledge
gained from this proposal may directly support the development of improved surveillance methods that
may aid future resistance outbreak prevention as a result of DNA donation. In Aim 1, we will use
experimental evolution of 10 commensal isolates to 6 antibiotics to nominate novel mechanisms of
resistance that may be available to pathogenic members of the genus. This aim builds on our published
work demonstrating the feasibility of rapid resistance evolution (< 20 days) in commensals, and the ease
of identifying the underlying casual mutations via whole genome sequencing. In Aim 2, we will use
population genomics to determine the genomic regions that demonstrate evidence of horizontal transfer
from commensals to gonococci. This aim will also provide evidence supporting the possibility of novel
derived mutations uncovered in Aim 1 and those that have previously been described, in being
maintained in natural populations. In Aim 3, we will validate novel resistance mechanisms and assess
their likelihood of transfer to N. gonorrhoeae. Transformations of candidate resistance mutations into
ancestral commensal strains (not evolved) and a piliated N. gonorrhoeae will together 1) prove causality
of novel mutations, and 2) provide experimental evidence of the likelihood of transfer into a Neisseria
pathogen. The PI has demonstrated that these experiments are feasible at the undergraduate and
graduate student levels, in both the research laboratory and in the classroom, and will provide
exceptional educational and training opportunities for RIT students.

Public health relevance
PROJECT NARRATIVE Neisseria gonorrhoeae has repeatedly been demonstrated to acquire antibiotic resistance from close commensal relatives within the genus yet the mutations encoding resistance that are harbored by commensals have been infrequently described. This limits our ability to predict novel resistance mechanisms that can be readily accessed across species boundaries and rapidly disseminated within pathogenic Neisseria populations. This project aims to nominate commensal resistance mechanisms that are direct threats to public health by testing the alleles that are at risk of transfer from commensals to pathogen using a combination of computational and experimental approaches.